Mechanisms of microtubule-based transport

PROJECT SUMMARY
The contents of eukaryotic cells are highly dynamic, yet organized spatially and temporally. This is achieved
primarily by the microtubule cytoskeleton and associated transport machinery, whose fundamental nature is
highlighted by the many neurological diseases caused by mutations in them. The overarching goal of my
research program is to understand how this system works at the molecular, cellular, and organismal
scales. My team is highly interdisciplinary and we use in vitro biochemical reconstitution, protein engineering,
single-molecule imaging, proteomics, live-cell imaging, and fungal genetics to achieve our goals. Through
collaborative projects we use cryo-electron microscopy (cryo-EM) and cryo-electron tomography (cryo-ET) to
incorporate a structure-guided approach to understanding intracellular transport, and we develop testable
quantitative physical models of transport. We have made major contributions to determining how the dynein
motor works and is regulated, to developing tools and screening strategies to study bi-directional movement of
cargos on microtubules, and to understanding the regulation of intracellular transport in cells. Fundamental
questions that we will address here include: (1) How does the dynein motor work? Our earlier work revealed
how Lis1, a protein mutated in the neurodevelopmental disease lissencephaly, interacts with dynein and
regulates its mechanochemical cycle. Here, we will focus on determining the mechanistic underpinnings for how
Lis1 promotes the formation of activated dynein/dynactin complexes. We will also explore a new direction—the
role of RNA editing—as a previously undescribed mechanism to regulate dynein and kinesin motors.
Microtubule-based motors move dozens if not hundreds of cargos. (2) How is cargo-specificity achieved? Our
past work used two complementary discovery-based approaches—genetics and proteomics—to identify
molecules responsible for specifying dynein’s many functions. One mechanism revealed by our past work is
organelle hitchhiking, where cargos link to motors indirectly, by attaching themselves to other cargos that are
directly bound to the motors. A second strategy for achieving cargo specificity is the expansion of dynein
activating adaptor genes in vertebrates. However, the molecular connections between most activating adaptors
and dynein’s cargo are unknown. Here, we will determine the mechanisms underlying hitchhiking and the
linkages between the Hook and Ninein families of activating adaptors and their cargos. As an additional approach
to understand how dynein and kinesin link to their cargos, we will visualize these connections in cells in three
dimensions using cryo-electron tomography of endosomes in Aspergillus nidulans and melanosomes in Xenopus
laevis melanophores, two systems where we can use exquisite genetics or chemical tools to control microtubule-
based motility.

Public health relevance
PROJECT NARRATIVE Transport inside cells is driven by molecular machines called dynein and kinesin, which move along cellular tracks called microtubules. Defects in the transport machinery cause neurodegenerative and neurodevelopmental diseases in humans. This research will provide key mechanistic insights into how these machines work and how they are regulated to move dozens of cargos.